B539 REFURBISHMENT&INFRASTRUCTURE UPGRADES TO B539/1ST FLOOR, PHASE 1

Work Order 124981: This segment of B539 is a one-story masonry and steel frame building with mechanical attic space. The B539 Ph 1 Refurbishment will encompass approximately 4,700 NSF. The Refurbishment upgrades will include the creation of animal facility and supporting laboratories and support rooms for the LASP CAPR program.